Mechanistic and Structural Studies of ERAD

Project Summary/Abstract
Maintaining protein homeostasis– the delicate balance between protein synthesis, folding, and degradation–
is essential for cellular health. Over a third of the cellular proteome and most membrane proteins are inserted
into the endoplasmic reticulum (ER) to become resident in this organelle or to enter into the secretory pathway.
Quality control (QC) mechanisms constantly monitor the proteome across secretory compartments– such as the
ER and Golgi apparatus– and promptly recognize and degrade misfolded proteins. But within each compartment,
the mechanisms by which QC machineries detect misfolded substrates for degradation remain unknown.
Whether the mechanistic principles for substrate recognition are shared across compartments also remains an
unanswered question. In the ER, when a protein cannot reach its native folded state, it is retro-translocated into
the cytosol, polyubiquitinated, and degraded by the proteasome, a pathway termed ER-associated degradation
(ERAD). Degradation of membrane-spanning proteins (ERAD-M) is mediated by the ubiquitin ligase Hrd1 but
how substrates are recognized by Hrd1 inside the membrane is not well understood. In Aim 1 (K99), I will test
the hypothesis that Hrd1 locally thins the membrane to trap and select substrates for degradation. This model would
explain how Hrd1 can recognize a broad range of substrates that expose diverse hydrophilic residues to the
membrane – a hallmark of ERAD-M. The Hrd1 complex can also handle misfolded proteins in the ER lumen (ERAD-
L). During ERAD-L, the substrate completely traverses the ER membrane from lumen to the cytosol, but how
Hrd1 mediates this process is unclear. I will address this question in Aim 2 (K99) by “trapping” the substrate on
Hrd1 as it crosses the ER membrane and by visualizing the complex using cryo-electron microscopy (cryo-EM).
This work will clarify important biological questions as ERAD exemplifies a unique protein translocation
mechanism that functions without the use of a signal sequence and a well-defined transmembrane channel.
Next, in the independent phase (Aim 3, R00), I will focus on the Tul1 ubiquitin ligase residing in Golgi membranes
and I will elucidate how it recognizes and handles its substrates. I will test the hypothesis that Tul1, like Hrd1,
thins the membrane to specifically recognize and select membrane-spanning substrates. I will address these
questions using expertise gained in the mentored phase, by visualizing the Tul1 complex in vitro by cryo-EM and
by employing novel degradation assays in cells. With continued guidance of my mentor Dr Tom Rapoport, the
Advisory Committee that will provide support in key aspects of my training, and the exceptional resources
provided by the Harvard Medical School, I am well positioned to successfully finish this work. The experience I
acquire during this award will fully equip me for career independence, where I will employ my skillsets to elucidate
the mechanistic principles of protein quality control in diverse cellular compartments.

Public health relevance
Project Narrative Timely disposal of misfolded proteins is required to maintain a functional proteome and cellular health. Quality control pathways constantly monitor the proteome, promptly degrading proteins that do not fold properly or expose other degradation cues. The goal of this proposal is to elucidate how aberrant proteins are recognized in order to reveal universal mechanistic principles underlying quality control in different cellular organelles.